CF 1: Biospecimen Repository Core

CF-1: Biospecimen Repository
ABSTRACT
The Biospecimen Repository Core (CF-1) is designed to provide support to the basic and translational
research efforts of the SPORE. The CF-1 will play a central role in collecting, annotating, storing,
distributing, and tracking of tissue and blood biospecimens from patients enrolled in research protocols.
The Core will provide SPORE investigators with expert histopathological evaluation of tumor samples
both from patients enrolled on research protocols and from murine and xenograft models. Additionally
it will assist in selecting appropriate formalin-fixed, paraffin-embedded tissue and snap-frozen tissue for
research and pilot projects, as well as enable the creation of tissue microarrays (TMAs) for SPORE
investigator studies. The Core will provide assistance in performing and interpreting
immunohistochemical studies and fluorescence in situ hybridization (FISH) assays. It will provide
scanning and digital archiving of TMA images and reliable interpretation, scoring, and archiving of IHC
results from frozen, paraffin-embedded sections or TMA sections. The core will also provide systematic
assessment of tumor response to therapy in human tissues and in sarcoma murine models, including
interpretation of immunohistochemical markers for drug response, such as changes in kinase
phosphorylation, proliferation inhibition, and induction of apoptosis. It also provides a centralized
resource for mutational annotation of sarcoma samples and cell lines using the IMPACT platform.
Finally, it ensures linkage to the clinical sarcoma database in collaboration with project leaders, the
bioinformatics core (CF-2 Qin/Socci) and the administrative core (Singer). This establishes a substantial
infrastructure and allows us to provide the required services in a cost-effective manner. The CF-1 is
tightly integrated with the MSKCC Institutional Pathology Core (supported by the MSKCC Cancer
Center Core Grant) and the Clinical Research Database (CRDB) managed by the administrative core.

Public health relevance
Core 1: Biospecimen Repository NARRATIVE The Biospecimen Repository Core (CF-A) will play a central role in the collection, annotation, and storing of all tumor samples and blood from patients diagnosed with sarcoma and enrolled on research protocols at MSKCC. The CF-A will provide expertise with pathology diagnosis and interpretation of ancillary techniques that will assist in the basic and applied research efforts of the SPORE investigators, and will provide information regarding tumor response to different drug therapies used in various clinical trials or applied to the animal models of sarcomas. It will also establish a significant infrastructure for other projects and cores in a cost-effective manner.